Regulation of the Immune Response to Plasmodium by IL-10 Producing Natural Killer Cells

Project Summary/Abstract

Malaria is a significant global health problem in which we still fail to understand many
protective features of the immune response. Natural killer (NK) cells produce
inflammatory cytokines during the early stages of infection, yet have also been shown in
viral models to limit T cell and B cell responses. We recently demonstrated that NK cell-­
produced IL-­10 can limit CD8+ T cell activity during experimental cerebral malaria and
thereby rescue mice from fatal, CD8+ T cell-­mediated immunopathology. Using newly
generated mouse strains, we will visual the location and cellular interactions of NK cells
in the brain and establish the cellular targets of NK cell-­derived IL-­10 during cerebral
disease. Our studies will also determine if distinct human NK cell subsets are more
efficient at producing IL-­10, and if these cells correlate with protection from malaria
symptoms in humans. Finally, we will investigate the impact of NK cell-­derived IL-­10 on
the development and function of memory CD8+ T cells. Our objective is to understand
how NK cell regulatory functions like IL-­10 production decrease immunopathology and
symptomatic infection, and shape the developing T cell response. The proposed work
will determine the consequences of NK cell-­derived IL-­10 during the immune response
to malaria and reveal ways to exploit regulatory NK cell function, thereby improving
immunity in populations at risk for severe disease.

Public health relevance
PROJECT NARRATIVE During malaria infection, humans can experience both parasite mediated disease and pathology resulting from an overly robust immune response. This project aims to understand how a rapidly functional immune cell called natural killer cells, can participate in both pathogen control and in limiting inflammatory responses. Our goal is to understand the significance of natural killer cells during malaria infection, and determine strategies for enhancing responses that protect people from symptomatic disease.